Cooperative Human Tissue Network (CHTN)

PROJECT SUMMARY / ABSTRACT
The Cooperative Human Tissue Network (CHTN) was established as a mechanism to provide the scientific
community with high quality human tissue biospecimens for cancer research. The CHTN allows investigators
to access the biospecimens they need to perform cutting-edge research, including basic and early translational
cancer research, and assay development.
As one of six CHTN Divisions, the Pediatric Division of the CHTN (pCHTN) will receive, process, and distribute
scientifically-relevant biospecimens collected from children, adolescents, and young adults. These
biospecimens can include malignant, benign, diseased, and uninvolved biospecimens. The pCHTN seeks to
directly promote and support cutting-edge research in the diagnosis and treatment of chronic disease and
cancer by pursuing the following specific aims:
1. To leverage the relationship with the Children’s Oncology Group, in addition to Nationwide Children’s
Hospital, to procure a wide range of well-annotated biospecimens from a variety of cancers, including
biospecimens from rare tumor types, and non-cancerous conditions.
2. To support cutting-edge research by distributing high-quality biospecimens to approved investigators.
3. To maximize limited biospecimen resources and provide economies of scale by performing additional
processing of biospecimens (e.g. nucleic acid extraction, tissue microarrays, digital images of stained
tissue slides, etc.)
4. To maintain a reliable and robust Quality Management Program that monitors all aspects of biospecimen
collection, processing, storage, and distribution in an effort to constantly evaluate and improve our
operational capabilities, assess best practices, ensure investigator satisfaction, and protect the privacy and
confidentiality of those individuals from whom the biospecimens and data were obtained.
5. To actively contribute to the CHTN by participation and collaboration in trans-Network interactions,
particularly in fulfilling highly-customized or non-standard requests, participating in collaborative Network
activities, and coordinating or developing new strategies to ensure that the CHTN remains responsive to
investigators’ needs.

Public health relevance
PROJECT NARRATIVE The Cooperative Human Tissue Network (CHTN) was established to address the increasing demand by the scientific community for access to high-quality human biospecimens for research. The goal of the Pediatric Division of the CHTN is to support pediatric and adolescent research (including cancer) by collecting, processing, and distributing high quality biospecimens.